Neonatal Research Network Data Coordinating Center (DCC) 2023-2028

PROJECT SUMMARY/ABSTRACT
Critical gaps in neonatal research require multicenter involvement and innovative designs to study them.
NICHD views the next chapter of its Neonatal Research Network (NRN) as its “primary and first-line
infrastructure” for conducting definitive, rigorous, and reproducible multicenter clinical research in newborns
that generates evidence to guide clinical practice. There is a crucial need for an independent Data
Coordinating Center (DCC) to provide sophisticated and impartial biostatistical and operational expertise that
helps the NRN target its resources and optimize its scientific impact by (1) helping identify research topics of
high priority, (2) providing objective statistical expertise for the design and analyses of rigorous and feasible
studies, (3) developing processes and systems to increase efficiencies and optimize effective usage of
limited resources through external partnerships that amplify the NRN scientific goals, (4) ensuring
standardization of study design, development, data collection and analyses, and (5) disseminating results.
RTI has been the DCC for the NRN since 1998 and proposes to continue in this role for the next 7 years. We
will maximize the scientific impact of the NRN by (1) collaborating in the development of rigorous and
innovative trial designs and statistical methods to address the unique challenges in neonatal research; (2)
optimizing productivity by providing flexible and efficient data/project management and study monitoring, and
promote data sharing, integration, and harmonization; (3) vigorously pursuing external partnerships to
support and amplify NRN scientific goals; (4) protecting participant safety and study integrity; (5) providing
timely data analysis and collaborative dissemination for all NRN studies; and (6) providing the logistical,
communications, and regulatory support necessary to run an efficient and productive multicenter clinical
research network. Dr. Abhik Das, the proposed PI, has extensive experience in neonatal clinical studies,
leading the NRN DCC for the past 17 years. He will be assisted by Alternate PI, Dr. Carla Bann, and staff
with significant NRN experience. This application has unique strengths to help advance the NRN research
agenda: (1) a highly qualified and motivated PI and staff with in-depth knowledge and years of experience in
neonatal research needs, enabling seamless continuation of NRN research without additional training or
resources; (2) proven track record of scientific productivity documented in the quality and quantity of NRN
studies and publications supported by RTI that have changed clinical practice, and leveraging the NRN
infrastructure to advance NICHD and NRN scientific goals; (3) a state-of-the-art infrastructure of tools,
processes, and systems that are flexible and customized to the needs of the NRN; (4) multidisciplinary
experts who can collaborate with NRN Investigators to realize research goals; (5) robust data management
systems customized for the NRN that ensure data quality; and (6) an agile administrative structure providing
maximum flexibility in staffing and contractual operations to respond quickly to changing NRN needs.

Public health relevance
PROJECT NARRATIVE NICHD established the Neonatal Research Network to investigate persistent unanswered questions regarding the safety and efficacy of treatment and management strategies for newborn infants. A Data Coordinating Center (DCC) provides essential expertise to such a large multicenter research enterprise by ensuring rigorous and consistent standards for study design, development, data collection, and data analyses. The DCC also provides objective statistical expertise for formulating, designing, and analyzing studies (especially, masked randomized trials and monitoring thereof), and coordinates communications, regulatory and logistical support across diverse clinical centers, both inside and outside the Network.